PPDs Application for the Transplantation Statistical and Clinical Coordinating Center (T-SCCC) (U01 Clinical Trial Not Allowed)

Project Summary/Abstract
To support DAIT's efforts to increase understanding of the causes and mechanisms that lead to the
development of immunologic diseases and to expand knowledge that can be applied to improving techniques of
diagnosis, treatment, and prevention, the T-SCCC will provide experienced staff, standardized procedures,
optimal facilities, and integrated systems to transition-in and support statistical and clinical coordinating
center deliverables for NIAID/DAIT's clinical research programs, investigator-initiated clinical trials, and other
NIAID-funded clinical programs in transplantation. The T-SCCC will empower DAIT's transplantation
researchers to address key scientific questions and share resultant data by efficiently managing program and
study resources and facilitating communication and collaboration among stakeholders from initial study and
protocol concepts through to peer-reviewed manuscripts.
The T-SCCC will: 1) provide experienced scientists and statisticians to collaborate with clinical investigators
and DAIT to develop innovative statistical design and analysis plans for concept and full study proposals;
conduct interim and final statistical analyses of clinical and mechanistic study data that will be used to that
yield optimal results for scientific manuscripts and reports for publication and presentation; 2) provide high-
quality adverse event/serious adverse event reporting that supports Data and Safety Monitoring Boards, other
safety committees/bodies, and regulatory health authorities in ensuring study participant safety; 3) provide
dedicated, experienced protocol teams to help develop, review, and revise protocols and protocol-related
documents and provide site training on protocol-related processes and procedures at startup and throughout
studies to accommodate changes; 4) establish and maintain a biospecimen tracking database and assemble and
ship assay kits and/or bulk supplies that include biospecimen labeling packets (kitting) for mechanistic studies;
5) help ensure complete, accurate clinical data collection and security by supporting data management plan
development and study database design in collaboration with the CDSMC, investigators, SMTs, and DAIT; 6)
collaborate with the CDSMC, SMTs, and DAIT to monitor study participant safety, implement of safety
procedures and adhere to safety oversight and reporting requirements; 7) provide and maintain secure, user-
permissioned, internet-based clinical study collaboration portals, to house clinical trial information and study-
specific files and provide a mechanism to receive study data securely from the CDSMC for analysis, reporting,
and sharing; 8) develop and implement plans for collaborative project management, communications, and
support of the complex web of stakeholders and processes involved in delivering the T-SCCC to ensure
efficient, valid, and ethical study oversight, reporting, and conduct; and 9) use well-developed standards and
methods to build and implement a comprehensive, cross-functional quality assurance/quality control plan that
standardizes quality processes across deliverables and facilitates assessments of T-SCCC performance.

Public health relevance
Project Narrative The T-SCCC's objective to provide a broad range of support critical to the design, development, execution, and analysis of DAIT-sponsored clinical research programs in transplantation will promote public health by increasing the accuracy, quality, availability, and timeliness of resultant study data. Services will include statistical design and analysis; clinical protocol development, implementation, and study management; biospecimen tracking (including a tracking database); biospecimen collection kits and/or bulk supplies for mechanistic studies (kitting); manuscript publication support, study management team (SMT) organization and maintenance, and collaboration with other DAIT stakeholders to plan, oversee, execute, and analyze this DAIT-sponsored transplantation research. The results from this clinical research will be essential to minimizing or removing barriers to short- and long-term success of transplantation procedures by reducing the morbidities associated with pharmacological immunosuppression, inducing transplantation immune tolerance, and improving understanding of the immunologic response to allotransplantation.